Duke University Program in Environmental Health

ABSTRACT
Environmental chemicals and stressors are major contributors to disease. Our ability to reduce harm is limited
by uncertainties about exposure, poor understanding of the exposures or exposure mixtures that cause health
effects and the mechanisms by which they do so, as well as by limited ability to remediate polluted sites and
treat diseases. Interdisciplinary expertise is required to rigorously quantify exposure and health effects to
assess and manage risk, and to develop novel tools for exposure reduction, remediation of polluted sites, and
treatment of disease.
The Duke University Program in Environmental Health (UPEH) rigorously prepares students for the
complexity of research careers in environmental health by leveraging and integrating the highly complementary
disciplinary strengths of Duke’s internationally-renowned Schools of Medicine, Environment, and Engineering,
and Departments of Biology and Statistics. The UPEH is a critical, keystone element of Environmental Health
research and training at Duke. It makes possible a larger, interdepartmental, transdisciplinary program called
the Integrated Toxicology and Environmental Health Program, which was initially created in 1978 in the Duke
Medical Center. By supporting predoctoral and postdoctoral training, the UPEH T32 creates a force-
multiplying environment that trains many more PhD students and postdoctoral Environmental Health
researchers than are supported financially by the T32. Importantly, Duke is fully invested in supporting this
training program, offering very extensive support for Environmental Health training that complements the
UPEH, and hosting twelve additional major environmental health-related centers and initiatives that
enormously enrich the learning environment for our trainees. Finally, while the outstanding Duke UPEH faculty
serve as primary advisors for trainees, the Program is further enriched by adjunct faculty and external advisors
from our neighboring Research Triangle Park-based institutions such as the NIEHS, US EPA, and RTI, and our
sister triangle universities (North Carolina Central University, NC State University, and UNC Chapel Hill).
UPEH trainees receive high-quality training including: (1) development of essential research skillsets including
content mastery in core disciplinary areas (Environmental Health, Toxicology, Exposure Science,
Epidemiology, Environmental Engineering, etc.), quantitative methods (Biostatistics, Exposure Science
Modelling, Big Data Analytics, etc.), and training in responsible conduct of research and rigorous and
reproducible experimental design; (2) critical and creative thinking, and a research mindset focused on
interdisciplinary problem-solving via cutting-edge, innovative research; and (3) knowledge, professional skills,
and experiences required to identify and transition into environmental health careers. The UPEH fosters a
supportive and inclusive training environment in which all trainees will prosper, evidenced by our increasingly
diverse trainee population and by the success of alumni.

Public health relevance
Narrative Environmental chemicals and stressors are major contributors to disease; interdisciplinary expertise is required to rigorously quantify exposure and health effects to assess and manage risk, as well as to develop novel tools for reduction of exposure, remediation of polluted sites, and treatment of disease. Duke University has outstanding expertise in these areas, with top-ranked Schools of Medicine, Environment, and Engineering; Departments of Statistical Sciences, Environmental Engineering, and Biology; and the Global Health Institute. Through integration of this transdisciplinary expertise, the Duke University Program in Environmental Health will provide pre- and postdoctoral trainees with essential research skillsets, guidance in professional development, and an inclusive and supportive training environment, thus producing deeply trained but interdisciplinary environmental health leaders who will contribute throughout their careers to solving society’s urgent environmental health needs.